Decoding and Selective Modulation of Human Memory During Awake/Sleep Cycles

PROJECT SUMMARY/ABSTRACT
Episodic memories integrate the content of human experience in space and time and constitute the core of one's
identity. Memory formation involves processing, and constructing interpretations of the incoming information in
our daily lives and is one of the first functions compromised in neurodegenerative diseases such as Alzheimer's
Disease. With population aging, we face a “Cognitive Tsunami” of millions of people with memory disorders.
Thus, understanding neural mechanisms of memory, and finding interventions that enhance these processes is
a critical endeavor with the potential to improve the lives of countless people world-wide.
Although it is established that memory is critical for cognitive well-being, and sleep is critical for memory
consolidation, the underlying mechanisms in the human brain are poorly understood. Research on memory and
sleep so far has suffered from a gap between non-invasive cognitive research in humans and detailed
electrophysiological research in animals. Moreover, most human studies are dominated by stimulus response
methodologies where the presented stimuli constitute limited, discretized, aspects of memory. This approach,
albeit well-controlled, is far from the rich narrative of episodes we experience. Thus, to mechanistically probe
human memory consolidation, it is imperative to (a) employ methodologies that incorporate the continuous and
multimodal nature of experience; (b) identify relevant neural activation patterns and how they are transformed
and reactivated during sleep; (c) establish means to causally modulate memory processes during sleep.
Building upon our exploratory U01 project, this proposal seeks a breakthrough in our understanding by
going beyond the state-of-the-art, and via the application of integrative and multidisciplinary approaches. It
capitalizes on a highly unique opportunity to record and modulate neuronal activity of a large number of
single neurons and neuronal assemblies in the human brain. In parallel, it exploits the high dimensionality
of the data as an asset through the use of cutting-edge Deep Learning (DL) algorithms, which have emerged
as promising analysis tools. Specifically, the project will investigate the presence, and decoding, of distributed
neural patterns associated with memory for different aspects of experience during wakefulness and identify
their reactivation during sleep. The proposal aims to selectively modulate memory via application of novel
closed-loop stimulation in sleep in concert with the DL model predictions.
We anticipate that this project is poised to shed light on the relationship between sleep and memory, and
its modulation from a novel perspective. Such an ambitious goal can only be achieved with unrivaled combination
of experience, access to a clinical setting, and interdisciplinary collaborations such as those proposed in this
project. By combining the opportunity to stimulate and record neural activity with the computational power of
artificial intelligence, this project aims to offer findings with far reaching implications for basic neuroscience and
contribute to the development of novel therapies for human memory disorders.

Public health relevance
PROJECT NARRATIVE Memory impairment and disruptions in sleep architecture co-occur in various neurological disorders, suggesting that elucidating the mechanisms underlying the entanglement between memory and sleep may offer the opportunity to improve the lives of people suffering from memory disorders as well as promote the significance of healthy sleep habits for the general public. The proposed multidisciplinary project seeks a transformative understanding of memory processes and consolidation during sleep by combining the unique capability of direct recordings from the human brain at multiple levels of resolution—single neurons, localized neuronal assemblies, intracranial local field potentials—in neurosurgical patients monitored with intracranial depth electrodes, and computational power of artificial intelligence. Furthermore, the project will probe causal mechanisms of consolidation by application of auditory and electrical stimulations—with high temporal and spatial precision— using innovative model-driven closed-loop technology, which can help lay the foundation for future therapeutic interventions of memory disorders.